A PORTABLE AND RAPID ASSAY FOR CANNABINOIDS

Environmental Diagnostics has long term objectives of developing and manufacturing inexpensive kits for use by industry, agriculture and government to screen for health related substances such as drugs-of-abuse, pesticides, etc. A specific aim of the Company is to further develop its patented immunoassay technology with innovations which will result in a screening kit for cannabinoids and, potentially, other drugs-of-abuse. At the conclusion of Phase I of SBIR, the Company expects to produce a laboratory prototype of a screening kit for cannabinoid which is sensitive to the low ng/ml range; rapid (5 minute test); suitable for use with either saliva, urine, or whole blood from a finger prick; easy-to-use requiring the addition of one drop of sample and additions of two reagents; hand-held requiring no instrumentation; configured for a potential shelf life of several months at room temperature; constructed of low cost materials; and ready for extensive testing and product development in Phase II. Such an accomplishment will involve several technological innovations and result in a potential for widespread commercialization in drug control and enforcement.